Advancing cross-disease comparisons through FAIR data practices to uncover shared molecular mechanisms between Alzheimer's disease and autoimmune disorders

Project Summary/Abstract
Recent studies have shown that individuals with systemic autoimmune diseases are at increased risk of
developing Alzheimer’s disease (AD). Shared dysfunctional mechanisms related to immune function likely
account for, or significantly contribute to, the development of both conditions. Identifying these shared
mechanistic pathways may lead to new treatment and prevention approaches. However, a critical bottleneck
impedes progress: the lack of integrated, interoperable, and analysis-ready data resources needed to detect
and explicate these shared mechanisms. This administrative supplement to the Accelerating Medicines
Partnership® (AMP®) Alzheimer's Disease (AD) Data Coordination Center (DCC) grant U24AG061340
proposes to address this gap by strategically enhancing the currently established infrastructure and catering to
the needs of the scientific community in these keystone areas of research.
In alignment with FAIR principles, a metadata framework, data storage and organization framework, and data
annotation process will be established within the existing ARK Portal for ingress of autoimmune and
immune-modulated diseases, leveraging the existing schema established for the AMP-AD portal. Alignment of
portal schema will facilitate cross-portal exploration of data. Support for data preparation and ingress will be
provided via the help desk, through the work proposed in Aim 1. For the proposed work in Aim 2, we will
enhance search functions, data visualization, access to data analysis tools, and exploration of available data
sets and, where appropriate, provide links to data within the AMP-AD portal relevant for comparison or
concurrent analysis for mechanistic linkages with autoimmune diseases. In an effort to reduce barriers to
accessing data for researchers within the ARK Portal, in Aim 3 Trusted Research Environments (TREs)
adhering to NIST SP 800-171 will be established to provide the same familiar research capacity across both
autoimmune and AD disease areas. Finally, Aim 4 will operationalize a Data Governance Framework for the
ARK Portal, ensuring data integrity, ethical use, and long-term stewardship in a complex landscape of data
sharing in the face of rapid developments in areas of AI/ML and evolving needs for data security and privacy.
This supplement is directly relevant to the parent grant's mission of data coordination, FAIR data
implementation, and resource dissemination. The ultimate impact will be the acceleration of research into the
shared biology of neurodegeneration and autoimmunity, providing a basis for the identification of novel
diagnostic biomarkers and therapeutically viable targets for both Alzheimer's and autoimmune diseases.

Public health relevance
Project Narrative Autoimmune diseases such as rheumatoid arthritis (RA) and lupus (SLE) affect millions of individuals, and compelling new evidence indicates that these conditions are associated with a significantly increased risk of developing Alzheimer’s disease. The goal of this project is to enhance the Arthritis, Autoimmune & Related Diseases Knowledge (ARK) Portal, making extensive research data on autoimmune diseases securely and easily accessible to scientists worldwide. Empowering researchers to investigate and compare the molecular underpinnings of these conditions and readily compare them to those in AD will significantly accelerate the discovery of shared causes and the development of novel treatments for both autoimmune disorders and Alzheimer’s disease.